Assessing Population-based Radiological brain health in Stroke Epidemiology (APRISE) Study

DESCRIPTION/ABSTRACT:
Stroke recurrence is a major public health problem. It has been understudied epidemiologically despite
comprising ~25% of all stroke in the US, and leading to higher morbidity and mortality compared to initial
events. Furthermore, compared to our understanding of the role of traditional risk factors for first stroke, we
have limited understanding of the risk factors for recurrent stroke. Radiological measures of small vessel and
large-vessel disease may provide a measure of a subject’s current “Brain Health” to predict future
cerebrovascular events and vascular dementia. Understanding small vessel disease in particular—manifesting
as white matter hyperintensity, microbleeds, lacunar infarcts, dilated perivascular spaces, and brain atrophy–is
a top NINDS priority. Although the Framingham risk score is widely used for clinical decision-making, and the
ABCD scores predict 90-day stroke risk among minor stroke/TIA patients, no clinical prediction tool in a
broader ischemic or a hemorrhagic stroke population-based cohort has been established. A Framingham-like
“Risk Function Tool for Secondary Stroke,” especially one incorporating the full gamut of modern imaging
parameters developed in a racially diverse population, would likely identify high-risk patients for targeted
education interventions, novel antithrombotics, and aggressive clinical care. Moreover, it may reveal novel
causal pathways and risk factors for future investigation. We propose an ancillary study to the ongoing Greater
Cincinnati/Northern Kentucky Stroke Study (GCKNSS) entitled APRISE (Assessing Population-based
Radiological brain health in Stroke Epidemiology). Our objective is to build on the GCNKSS infrastructure
to radiologically characterize the full stroke/TIA population of Greater Cincinnati/Northern Kentucky from 2015
and create the first modern, largely MRI-based characterization of brain health in a contemporary stroke/TIA
population. Our specific aim is to create a prediction model of cerebrovascular disease recurrence
(ischemic or hemorrhagic stroke) incorporating imaging parameters in a biracial, large-scale ischemic
stroke/TIA population using state-of-the-art modeling approaches. We will achieve these goals by
radiologically characterizing the stroke/TIA population (~2700 ischemic and ~525 hemorrhagic stroke, and
~1025 TIA patients) in the NIH-funded GCNKSS of a 1.4 million, biracial population. We will leverage the
extensive GCNKSS infrastructure, which is already in place to detect recurrent stroke, placing us in a unique
position to develop a recurrent stroke risk model using newly acquired radiologic data with remarkable
efficiency. The proposed study will allow the first and only population-based characterization of the entire
imaging spectrum of brain health in stroke/TIA patients. Our multi-disciplinary team with imaging,
epidemiology, outcomes, and biostatistics expertise will address NINDS priority research areas with precision
and innovation currently unavailable.

Public health relevance
NARRATIVE: Stroke recurrence (or a second stroke event after an initial stroke) is a major public health burden. The APRISE (Assessing Population-based Radiological brain health In Stroke Epidemiology) study will analyze imaging to understand brain health at the population level and create models to predict stroke recurrence.